Developing and Discovering Covalent Inhibitors through Fragmentation-First Experimentation

Abstract
Iterative chemical innovation plays an essential role in the study and treatment of disease. In an aging
population and with antimicrobial resistance on the rise we could not be more dependent on state-of-the-art
medicines to battle cancer and infectious disease. However, despite nearly two centuries of important progress
in chemical synthesis the cycle time for discovering new medicines lies far behind the pace of evolutionarily
acquired resistance. The existential threat posed by this lack of synthetic agility requires bold new strategies
which contract the time for data collection and chemical optimization. The research described in this proposal
leverages a conceptually novel framework which dramatically simplifies access to small molecules and the
processes to impact prioritize their reactions with biomacromolecules. In fragmentation-first experimentation
the fundamental fragmentation patterns which underlie chemical reagents define precise barcodes for
scrutinizing the outputs of high-throughput chemical synthesis. In contrast to existing strategies which require
per-product customized protocols, this approach connects chemical reaction analysis directly to the synthetic
origin of a chemical product. The net effect is a dramatic reduction in opportunity cost associated with making
new chemical matter and a concomitant contraction of the cycle time for new discoveries. The net effect is a
shift in focus away from making molecules and toward finding new functions. Empowered by high- content
access to chemical matter we will unify these approaches with methods to directly study the reactions of small
molecules with proteins and bacteria ribosomes to identify more effective covalent inhibitors. Parallelized
interrogation of biological targets will provide detailed structure interactivity data to iteratively inform molecular
designs. A unifying feature of these approaches are that small molecules can be directly utilized to determine
their biological activity without purification, thereby eliminating another slow step in the molecule making
process. If successful, our proposed research program will dramatically shorten the timeline for developing
reactive small organic molecules (covalent inhibitors) and reduce the material burden for exploring their
structure reactivity relationships. Fundamental new characteristics in the design of reactive small molecules
uncovered throughout the course of our investigations will contribute to our ability to innovate on the molecular
scale.

Public health relevance
Project Narrative Small organic molecules have transformed our capacity to study biology and treat disease, but a lack of synthetic agility renders this space vulnerable to evolutionarily induced resistance. This proposal describes a modular framework for ultra-high throughput synthesis and ranking of covalent inhibitors for their capacity to react with proteins and ribosomes. If successful, these research activities will provide systems and tools enabling the rational design of precision medicines to combat infectious disease and cancer.